IMSD@Brown

Project Summary/Abstract
This program will address shortages in science of individuals from underrepresented (UR) groups, including
those from UR racial, gender, gender identity, ability groups and educationally disadvantaged background,
by strengthening Brown’s capacity to train more diverse Ph.D. cohorts. Using our IMSD Program as the
primary vehicle for change we will: a) Increase the numbers of UR students completing a Ph.D.degree and
pursuing careers in the biological, biomedical, & public health sciences and interdisciplinary fields to levels
proportional to their representation in the U.S. population. This will be achieved by strengthening and
expanding our successful BioMed IMSD program to other Ph.D. programs where biological training occurs.
This updated program, IMSD@Brown, will implement and establish practices that promote, improve and
sustain STEM student Ph.D. training and post-training success. It will drive increases in student
compositional diversity, institutional culture & climate, student retention & degree attainment.
IMSD@Brown will operate as the central integration hub that aligns graduate level diversity and inclusion
training practices across all programs and will institutionalize best practices by leveraging them to the benefit
of the larger Ph.D. student population across all STEM programs. The program’s practices include: 1)
developing inter-institutional relationships that serve UR students and our goals for excellence; 2) equipping
graduate programs with IMSD resources and tools that complement locally provided disciplinary-specific
training and coursework. These include training support for didactic, research, mentoring, and advising
support, training through IMSD skills-based modules, and IMSD community-building programming to foster
a sense of belonging for all students; and 3) Investing in processes that make permanent a culture that values
and promotes diversity and inclusion. IMSD Program faculty will be drawn from 21 STEM Ph.D. programs –
all of which engage in biologically & biomedically related work- to support 15 UR Ph.D. students appointed
yearly for 12 months as IMSD trainees. We will meet our, and the goal of NIH, by a) building relationships
which support UR students and enable their graduate and post-training career success, and b) improve
program outcomes by collaborating with faculty, partner institutions and the extended alumnae network
which our trainees can ‘tap’ into and c) lay the groundwork for broader change across Brown by embedding
best practices in all Ph.D. training programs.

Public health relevance
Project Narrative This program will establish the IMSD@Brown T32 Program as the institutional Integration Hub for broadening graduate diversity across multiple STEM Ph.D. programs to create a critical mass of outstanding and diverse research scientists, scholars and educators. IMSD@Brown will: a) develop the academic, co-curricular scaffolds around participating trainees, b) build an institutional culture of increased diversity and inclusion across all STEM disciplines, c) support interdisciplinary training and d) strengthen mentoring, advising and professional development practices across all programs. IMSD@Brown will drive and sustain improvements in compositional diversity, in institutional climate, and in culture change by preparing scholars skilled and equipped to join the U.S. scientific biomedical workforce to advance human health and knowledge, and track progress using formative and summative evaluations.